Integrative Center for Precision Nutrition and Human Health

PROJECT SUMMARY
This proposal submission responds to a call for an Administrative Supplement to Existing NIH Grants for
Equipment Purchase in which the Integrative Center for Precision Nutrition and Human Health (COBRE-
Nutrition) at the University of Hawaiʻi at Mānoa aims to purchase a total reflection X-Ray fluorescence (TXRF)
Spectrometer model S4 T-Star 200 manufactured by Bruker AXS LLC. The TXRF spectrometer is a state-of-the-
art benchtop equipment to rapidly analyze ultra-trace element content in various samples, including biological
fluids, food/supplements, cells, tissues, cell culture media, water, and other environmental samples, using small
amounts of sample and with a detection limit at the ppb range. The specific aims of this Administrative
Supplement request are: 1) to purchase a TXRF system to the UH community to be administered by a Core
Facility inside the COBRE-Nutrition infrastructure; and 2) to provide access, training and technical support to
researchers from the broad UH community in the use of the TXRF system. The TXRF will be housed in the
Lipidomics Core Facility under the CRAFT structure of the COBRE-Nutrition. Proposed users include Research
Project and Pilot Project Leaders of the COBRE-Nutrition, and multiple funded PIs from colleges and schools of
the UH system. The COBRE-Nutrition benefits directly through expanding the breadth of several scientific project
outcomes.

Public health relevance
PROJECT NARRATIVE This proposal submission responds to a call for an Administrative Supplement to Existing NIH Grants for Equipment Purchase in which the Integrative Center for Precision Nutrition and Human Health (COBRE- Nutrition) at the University of Hawaiʻi at Mānoa aims to purchase a total reflection X-Ray fluorescence (TXRF) Spectrometer model S4 T-Star 200 manufactured by Bruker AXS LLC. The TXRF spectrometer is a state-of-the- art benchtop equipment to rapidly analyze ultra-trace element content in various biological and environmental samples, including biological fluids, food/supplements, cells, tissues, and water, using small amounts of sample and with a detection limit at the ppb range. The TXRF will be housed under the CRAFT structure of the COBRE- Nutrition and its anticipated user base includes PIs from four different schools of the UH system, and benefits directly projects from Research Project Leaders and Pilot Project Awardees of the COBRE-Nutrition.